RESPIGAM (RSVIG IV) FOR REDUCTION OF RSV HOSPITALIZATION IN PREMATURE INFANTS

The aim of this study is to determine if administration of RSV-immunoglogulin can effectively prevent RSV infections or hospitalizations due to RSV in a high reisk population.